Repeat enhancers as drivers of ETV6-RUNX1+ and ETV6-RUNX1-like B-lymphoblastic leukemia

PROJECT SUMMARY
Genetic subtypes of B-cell acute lymphoblastic leukemia (B-ALL) bearing aberrations of the ETV6 gene,
including the ETV6-RUNX1 fusion gene and inactivating mutations of ETV6, are collectively among the most
common subtypes of B-ALL in children. However, our understanding of the biological basis of this common
disease has stalled, in part because mouse models have failed to recapitulate many aspects of the human
disease biology. We have identified a novel mechanism that directly ties aberrations in ETV6 function to the
cancer-specific gene expression programs that define ETV6-altered subtypes of B-ALL. We have shown that the
ETV6 transcriptional repressor binds to microsatellite repeats with the sequence ‘GGAA’ in B-ALL with intact
ETV6. In B-ALL with defective ETV6 function, repression of these repeats is lost. These repeats are bound by
the ETS activator ERG and other unidentified factors, take on an active enhancer-like state, and directly activate
the expression of long-identified ETV6-RUNX1 signature genes, including oncogenic pathway regulators.
Because GGAA repeat locations are not conserved between humans and mice, we believe that these specific
regulatory relationships can only be studied in human cells.
In this project, we will use innovative methods to study the activating mechanisms of GGAA repeat enhancers
and their specific effects on leukemia fitness in human leukemia cell lines, samples, and xenografts. We will
provide direct evidence for GGAA repeat enhancer activation as the causative mechanism for the subtype-
defining gene expression signature of ETV6-RUNX1-like B-ALL, a rare but aggressive B-ALL subtype. We will
identify how pervasive repeat enhancer activation affects global and local chromatin interactions, and identify
epigenetic barriers to de novo repeat enhancer activation. We will use a proteomic approach with engineered
repeat-binding proteins to identify the factors that cooperate in the setting of ETV6 loss to directly activate GGAA
repeat enhancers in B-ALL. Together, these investigations will provide answers to critical questions about the
biology of this common childhood cancer, opening new potential opportunities for therapeutic de-intensification
or prevention.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because ETV6-RUNX1+ B-lymphoblastic leukemia (B-ALL) is one of the most common cancers of children, requiring many months to years of intensive therapy for cure, with some patients relapsing and dying. Understanding the fundamental driver mechanisms that sustain malignancy in this cancer and a rarer but more aggressive subtype, ETV6-RUNX1-like B-ALL, could lead to less toxic therapies.